Novel functions of PlexinB2 in circulating tumor cell clusters

Abstract
The outcomes of cancer metastasis result from the dynamic battles and interactive reprogramming between
malignant cancer cells and the host defense system, especially immune cells. As one of the most challenging
and unmet tasks in the cancer clinic, effective metastasis control or prevention demands better understanding
and targeting strategies to reprogram the tumor-host ecosystems. The interplay is not only determined by
evolving heterogeneity and regeneration of tumor cells but also the fitness of immune system. While tumor-
infiltrated immune cells have been relatively well studied, the interactions between white blood cells (WBCs) and
circulating tumor cells (CTCs) are only at the beginning to be elucidated. In this proposal, our goal is to identify
molecular regulators of CTC-host interactions in one of the most aggressive subtypes of breast cancer, triple-
negative breast cancer (TNBC) which lacks expression of estrogen receptor (ER), progesterone receptor (PR),
and HER2 for targeted therapies, thereby blocking its metastasis to visceral organs such as the lungs. Combining
computational ranking of proteomic candidates, tumor specific expression, and clinical association of breast
cancer outcomes, we have identified one of the top enriched surface proteins in TNBC, PlexinB2 (PB2), which
drives the formation of homotypic tumor clusters and heterotypic CTC-monocyte clusters through interactions
with the Semaphorin ligands. CTC clusters with properties of stem cell plasticity and immune evasion are
considered the seeds of distant metastases which account for 90% of solid tumor-related mortality. We
hypothesize that targeting the PB2 pathway interferes with CTC-immune interactions and inhibits metastasis of
TNBC. Three specific aims are proposed to test the hypothesis: (1) determine clinical relevance of the PB2
network in human TNBC, (2) dissect the molecular mechanisms underlying PB2-driven CTC cluster formation,
and (3) targeting PB2 in CTC clusters and metastasis in preclinical modelsin vivo. As proof-of-concept, anti-PB2
neutralizing antibodies provide a new therapeutic opportunity to block CTC clusters and metastasis in TNBC.

Public health relevance
PROJECT NARRATIVE This proposal focuses on elucidating tumor host interactions in breast cancer using tools of computational modeling and experimental biology. Since breast cancer is the lead cancer worldwide and in the Unites States, the goal of the proposal is to identify new diagnostic and therapeutic approaches for targeting the tumor cells, boosting anti-tumor immunity, and improving human health.